Multi-Omics Core C

MULTI-OMICS CORE C SUMMARY
This PPG is addressing an important hypothesis that early life stress (ELS) leads to reprogramming throughout
the body resulting in an increased risk of developing CVD in adulthood. The mechanistic links between ELS and
CVD and resilience in adulthood is not established. Epigenetic regulation of transcription or the gut microbiome
and microbial-derived factors are hypothesized to be sensitive to ELS and may be modifiable to mediate
resiliency. The primary goal and function of the Multi-omics Core (Core C) is to provide start-of-the-art processing
of samples for determination of transcriptomes, DNA methylomes, DNA chromatin accessibility, metabolomes,
and microbiomes required by all Projects. The objective of the Core is to provide consistency and rigor in the
multi-omics experiments and provide innovative technologies to meet the goals of the Projects. The specific aims
of Core C are: Aim 1 Transcriptomic and epigenomic determination. The epigenome is an important
connection between the environment and the genes expressed in each cell (transcriptomes) and it is regulated
by DNA methylation and chromatin structure (accessibility). Core C will facilitate determination of transcriptomes,
and epigenome global DNA methylation and chromatin accessibility for the Projects. Aim 2: Microbiome and
metabolite profiling. In this PPG, it is hypothesized that ELS results in gut microbial diversity changes that
result in significant alterations to circulating short chain fatty acids (SCFA) or other metabolites. Core C will
prepare samples for microbiome 16S sequencing for identifying and quantifying microbial diversity. The Core
will also prepare samples for SCFA and untargeted metabolite determination by mass spectrometry. Aim 3:
Evaluating new technologies, optimization while promoting fiscal responsibility. In this era of multi-omics,
technologies are rapidly evolving. Thus, to provide the Projects with the latest technologies to test their
hypotheses, Core C will evaluate new technological platforms. Core C will optimize all protocols for sample
preparation for the multi-omics approaches listed above. By centralizing the mutli-omic sample preparation in
Core C, we will purchase kits and reagents in bulk leading to substantial cost savings. Core C will interact directly
with all Projects, receive clinical samples from Core B, and work directly with Core A for sample identification,
curating, data deposition and analyses, and data management. Core A will complete all bioinformatics and
biostatistical analyses for data generated in Core C. The approaches used in Core C ensure that the PPG is
using the latest technologies for determining mechanisms of ELS induced cardiovascular disease risk with a
bench to beside approach.

Public health relevance
MULTI-OMICS CORE C NARRATIVE Early life stress is a significant and understudied risk factor for increasing cardiovascular disease risk later in life. Core C will prepare samples and coordinate multiple genome wide analyses (multi-omics) from the level of a single nucleus to the tissue for all the Projects in this grant application. Centralizing the multi-omic approaches in Core C will ensure rigor and reproducibility of experimental design and data collection to meet the goals of this highly functioning PPG.